Chromogranin A is an aging risk factor

PROJECT SUMMARY
Chromogranin A (CgA) is a component of dense core vesicles of endocrine and neuroendocrine cells and
neurons that control the storage of neurotransmitters and hormones. CgA is a prohormone which is
processed into peptide hormones with distinct biological functions. Two of these peptides, catestatin (CST:
hCgA352-372) and pancreastatin (PST: hCgA250-301), exhibit diametrically opposite functions: CST is anti-
hypertensive, anti-inflammatory, and anti-diabetic, whereas PST is pro-inflammatory, pro-hypertensive and
pro-diabetic. High levels of CgA are present in the blood of patients with malignancies, inflammatory
diseases, and neurological disorders, and their levels rise as their clinical conditions worsen. Although Chga
(gene encoding CgA)-null mice have been available for nearly 20 years and have been widely studied, the
impact of CgA on aging has not been investigated. We found that CgA-KO mice develop hypertension at a
young age, but it reverses beyond the age of 12 months. We also noted that a few unused CgA-KO mice (all
male) that were kept aside lived at least 40 months. We also found that mRNA levels of lipoprotein lipase
(LPL), which controls triglyceride levels and V-set and immunoglobulin domain containing 4 (Vsig4), which
control bacterial clearance via autophagy, are low in the heart and liver of CgA-KO young mice but high in
old mice. We further found that leakage of bacterial DNA to other different organs in older WT mice. These
preliminary observations imply that CgA is an aging-inducing factor, but it has a positive role at early
ages through maintenance of lipid metabolism. We propose that differential processing of CgA into CST
and PST would determine aging through regulation of factors involved in metabolism and inflammation. This
proposal aims to investigate the validity of our hypothesis by assessing the lifespan, growth, mitochondrial
health, energy expenditure of a larger cohort of WT and CgA-KO males and females. We will further
determine the factors critical for CgA-induced aging and the pathways involved in the spontaneous reversal
of hypertension and lifespan extension of CgA-KO mice with emphasis on the lipoprotein-adipokine,
catecholamine-adrenergic receptor and Vsig-4-autophagy signaling axes in four different tissues.
The proposed research will be led by two Co-PIs: Dr. Mahata, a physiologist whose research focuses
on hypertension, insulin resistance and immunometabolism, and Dr. Ghosh, a biochemist who studies
inflammatory responses through the IKK-NF-B signaling pathways. If the hypotheses prove to be correct,
long-term studies to determine the underlying mechanisms of CgA-induced aging will be conducted.
Experiments proposed here will also help to determine if CgA can be targeted for therapy against
inflammatory disorders, aging-related and neurological disorders by lowering CgA transcripts at an older age
to reduce the pathogenic repercussions.

Public health relevance
PROJECT NARRATIVE Chromogranin A (CgA), the most ubiquitously distributed protein in the hormone-producing cells in our body, is overexpressed in patients with neuroendocrine and non-neuroendocrine malignancies, heart failure, renal failure, liver dysfunction, hypertension, and numerous autoimmune disorders such as rheumatoid arthritis and inflammatory bowel disease as well as in the brains of Alzheimer’s disease patients, implicating that excess CgA is toxic to many cellular activities. We found that lack of CgA in a mouse model caused marked improvements in the age-associated increase in blood pressure and diabetes with consequent increase in healthy lifespan. This proposal will use a transdisciplinary approach to uncover if CgA is a risk factor for aging by analyzing the lifespan of CgA knockout mice and whether removing CgA from adult animals will help ameliorate aging associated development of inflammatory disorders like diabetes and hypertension.